The Effect of Low Volume Sprint Interval Training on Cardiorespiratory Fitness; A Randomized Controlled Trial

Project Summary
Low levels of physical activity (PA) and cardiorespiratory fitness (CRF) are significant issues for
societal health. Public health guidelines for adults recommend > 150 min of moderate-intensity
continuous training (MICT) or 75 min of vigorous exercise per week, and strength training on > 2
days per week (U.S. Department of Health and Human Services, 2018). However, in 2020, 75%
of adult Americans did not meet these PA recommendations (Elgaddal et al., 2022). Physical
inactivity is the fourth leading cause of death worldwide (Kohl et al., 2012) as it increases the risk
of 40 chronic conditions (Ruegsegger and Booth, 2018). Low maximal oxygen uptake (V̇O2max;
the gold standard index of CRF) is strongly associated with increased risk of future morbidity and
all-cause mortality (Ross et al., 2016, Lang et al., 2024). In fact, many large-scale studies have
reported V̇O2max to be a more powerful predictor of risk for future morbidity and all-cause
mortality than more traditional risk factors such as smoking, hypertension, obesity, high
cholesterol, and insulin resistance (Myers et al., 2002, Kodama et al., 2009, Fogelholm, 2010,
Kokkinos and Myers, 2010). For population-level health, the largest benefits from improved PA
and CRF are gained by the least fit individuals, with even small increases in fitness shown to
improve health (Kodama et al., 2009). Despite exercise being the only viable means to improve
V̇O2max, it remains underutilized for primary disease prevention (Ekkekakis, 2021, Hanssen et
al., 2022). Nevertheless, adults do not engage in PA due to a perceived lack of time. High
intensity interval training (HIIT) is a time-efficient form of PA requiring brief intense bursts of
activity separated by rest periods. Empirical data show that HIIT elicits similar and in some cases
superior benefits versus MICT, often with less time. A special type of HIIT is reduced exertion
high intensity interval training (REHIT) requiring only two 20 second sprints within a 10 minute
session. A few studies show that REHIT increases CRF and other health-related outcomes, yet
these studies have been criticized due to their small sample size, which serves to question the
broad application of REHIT in adults. The proposed randomized controlled trial will recruit 60
inactive adults to complete 24 sessions of REHIT and compare resultant changes in CRF,
substrate metabolism, and psychological responses to a non-exercising control group. This
sample size is threefold higher than used in prior work and provides adequate statistical power to
detect meaningful increases in V̇O2max. The proposed study will advance further research in the
area of HIIT and if successful, may promote inclusion of REHIT in PA recommendations as a
feasible alternative or adjunct to moderate or vigorous-intensity exercise as promoted in current
PA recommendations.

Public health relevance
Project Narrative Prior studies show significant increases in cardiorespiratory fitness and other health-related outcomes in response to reduced exertion high intensity interval training (REHIT), yet these studies are characterized by small sample sizes which casts doubt on the true efficacy of this form of physical activity for enhancing health status. We propose a randomized controlled exercise training study in a large sample of inactive adults examining the effects of 8 weeks of REHIT on outcomes related to cardiometabolic health in comparison to a non-exercise control group. Data from the proposed study will advance physical activity research by bolstering the implementation of REHIT which will contribute to reduced risk factors of cardiovascular disease and in turn, improved public health.